An Observational Cross-Sectional Study of Virtual Reality Mobility Assessment of Functional Vision in Retinal Disease

The primary outcome is to determine whether parameters from a recently developed VR mobility tool can serve as biomarkers of functional vision in participants with retinal disease.
To this end, we will examine the correlation between VR mobility test parameters (e.g., accuracy, task time) and the mobility score from a PRO questionnaire/s.
Secondary outcomes include:
1. The correlation between VR mobility test parameters (e.g., accuracy, task time) and clinical measures of retinal structure and function (e.g. visual acuity, non-seeing area).
2. Learning effect on and test-retest variability of the VR test parameters.
3. Sensitivity of VR mobility test parameters to the presence and severity of retinal disease.
4. Feasibility of the tool based on age and presence of physical disabilities.
5. The effect of prior or present computer game playing (e.g., number of hours, type of games played, computer game platform) on baseline performance on the VR mobility tool.

Although we were notified of approval on February 3, 2020 we have not be able to start recruiting for the study due to suspension of clinics visits at the NIH clinical center during the pandemic. The VR software is in the process of being upgraded to take advantage of improvements in the VR environments available and improvements in VR goggles.